Easy-to-Operate Endoscopic Automatic Gastroplasty Device That Mimics the Effect of Gastric Bypass/Bariatric Surgery for the Treatment of Diabetes and Obesity

Project Summary/Abstract
According to the CDC, the prevalence of obesity among US adults 20 and over is 41.9 %. These over 100
million people are at an increased risk for diabetes, coronary heart disease, stroke, sleep apnea, stroke, gall
bladder disease, several types of cancer, and certain musculoskeletal disorders. The estimated annual medical
cost of obesity in the United States is $173 billion. Obesity leads to over 300,000 premature deaths each year
in the US. Obesity is a public health emergency.
Operative therapy for obesity is effective but at considerable cost, limited patient applicability, and with
substantial risks. Glucagon-like peptide-1 (GLP-1) medications induce initial weight-loss but also at
considerable cost and have many adverse effects as well as unknown long-term effects. Specialized
endoscopists are now performing highly operator-dependent “freehand” endoscopic sleeve gastroplasty. A new
non-surgical/non-pharma-based weight-loss solution that is easy to perform is needed.
InTailor Bariatrics, LLC and Edward Lin, DO, Chief of Gastrointestinal & General Surgery at Emory University
School of Medicine, have developed a patented technology for endoscopic gastroplasty that requires no
surgical cutting and can be completed in a 15-minute outpatient procedure.
The technology creates a substantial reinforced circular plication of invaginated tissue within the stomach
incorporating the entire circumference of the organ to produce a gastroplasty that reduces the volume of the
stomach and creates a restrictive pouch. The circumferential plication features a serosal-to-serosal tissue
apposition, creating dense fibrous appositions of the serosal fold, enabling a durable augmentation. The
created gastroplasty limits the amount of food a person can consume in one sitting. Weight-loss is achieved
without substantial modifications in the anatomy of the alimentary tract. The device’s ease of use enables
reproducible results that will foster widespread adoption.
In the proposed STTR Phase I project the specific aims of our project are: 1) Validate our next-gen prototype
by modeling endoscopic gastroplasty in an animal model 2) Evaluate short-term gastroplasty durability and
safety after 30-day survival with endoscopic relook, 3) Conduct post-mortem examination of the gastroplasty
structure and tissue integrity.
Phase II work will focus on refining the device design, completion of a 6-month animal survival study, and
continued communication with the FDA to design and complete a human pilot study.

Public health relevance
Project Narrative According to the CDC, over 100 million people in the US are at an increased risk for diabetes, coronary heart disease, stroke, sleep apnea, stroke, gall bladder disease, several types of cancer, and certain musculoskeletal disorders due to their obesity. Traditional bariatric surgery and GLP-1 agonists are not appropriate for every patient. This research will evaluate the utility of a technology that is designed to easily create an endoscopic gastroplasty. The availability of a simple-to-operate non-surgical/non-pharmacological long-term weight loss therapy is vital to this patient population.